Center for Public Information on Population Research

Project Summary/Abstract
PRB will maintain a Coordinating Center for the NICHD Population Dynamics Centers Research Infrastructure
Programs to improve the translation and dissemination of population dynamics research findings and methods
in a cost-effective and efficient manner. The Coordinating Center will promote policy-relevant research on
demography, reproductive health, and population health to a broad audience of stakeholders who can use the
information for decision making. In addition, the Coordinating Center will foster cooperation activities and
communication across NICHD Population Dynamics Centers to enhance the productivity and scientific impact
of both the Centers themselves and population dynamics research overall. The Coordinating Center will
accomplish these objectives through a complementary set of activities: 1) Maintaining a multi-Center website
that explains and publicizes the findings of research from the Population Dynamics Research Centers; 2)
Disseminating research through a series of eight concise, online articles, or “Research Highlights” during the
project period; 3) Using social media to connect with Center researchers and promote their findings to a broad
audience; 4) Distributing a quarterly e-newsletter that highlights research news from the Centers, information
about new Center grants, and funding opportunities; 5) Organizing two webinars focused on communicating
research results to journalists and other nontechnical audiences; and 6) Requesting feedback from population
dynamics researchers on Coordinating Center activities.

Public health relevance
Project Narrative A Coordinating Center for the NICHD Population Dynamics Centers Research Infrastructure Programs will improve the translation and dissemination of major peer-reviewed findings from population dynamics research to multiple audiences, facilitating the adoption of relevant findings for health research and practice. It will also improve synergy across the Population Dynamics Centers, enhancing the productivity and scientific impact of the Centers and of population dynamics research overall.